Novel Mechanisms of tau and TDP-43 synergy in Alzheimer's disease

Alzheimer’s disease (AD), a severe progressive neurodegenerative disease of aging and the most common
form of dementia, affects an estimated 30 million people worldwide. The presence of both amyloid plaques and
neurofibrillary tangles pathologically define AD, however, TDP-43 pathology often occurs comorbidly with AD
and correlates with more rapid cognitive decline and faster rates of hippocampal atrophy. We have previously
shown that there is a synergistic relationship between tau and TDP-43 in a novel C. elegans model of
combined tau and TDP-43 proteotoxicity, however the mechanisms that drive this interaction are unknown. In
our C. elegans models we have performed bulk RNA sequencing to compare gene expression in transgenic
animals expressing tau and TDP-43 alone and in combination. Preliminary results show that while tau
pathology alone results in an upregulation of genes encoding lysosomal enzymes, these same genes show
decreased expression in the combined tau and TDP-43 animals. We hypothesize that tau promotes a
compensatory upregulation of the lysosomal autophagy pathway, as has been observed in human AD
sequencing studies, but the combination of tau+TDP-43 impairs this response. In Aim 1 we will further
interrogate this potential mechanistic pathway of tau and TDP-43 synergy by targeting specific genes involved
in the lysosomal autophagy pathway in our C. elegans models of proteotoxicity. We will pair these functional
assessments with a highly quantitative and spatially preserved interrogation of well-characterized human post-
mortem samples to establish relevance to human disease and identify additional mechanisms of tau+TDP-43
synergy. One reason these pathways have remained elusive may be due to the heterogeneity of pTPD-43
pathology observed in AD. Distinct subtypes of pTDP-43 pathology have been described and our preliminary
data suggest different relationships exist between tau and TDP-43 depending on the subtype present. In Aims
2 and 3 we will use NanoString technology to measure both protein and gene expression in key brain regions
along the trajectory of pTDP-43 pathologic progression, taking into account the pTDP-43 morphologic subtype.
Together, these studies will identify potential mechanisms that underly the observed synergistic proteotoxicty
of tau and TDP-43, significantly advancing our understanding of the role of TDP-43 in the pathophysiology of
AD and ultimately contributing to novel treatment and diagnostic strategies for AD with comorbid TDP-43
pathology in future work.

Public health relevance
The combination of TDP-43 pathology with Alzheimer’s disease (AD) has devastating clinical and pathological effects but the underlying mechanisms have remained elusive. We propose an integrated study that combines functional studies performed in C. elegans models of combined proteotoxicity with highly quantitative spatial proteomics and transcriptomics in human brain tissue. These studies will identify unique pathways related to the synergistic proteotoxicity of tau and TPD-43 in the setting of AD with and without different TDP-43 subtypes and advance our understanding of the role tau+TDP-43 synergy plays in AD severity and progression, ultimately leading to novel diagnostic and therapeutic approaches for AD with comorbid TDP-43 pathology.